Epigenomics Core

Abstract – Epigenomics Core
The growth of genomic regulation research at OMRF over the past ~10 years has been supported by the OMRF
Clinical Genomics Center. This initially COBRE-supported core brought next generation sequencing capabilities
to OMRF to support studies on the genetics of immunity. These sequencing capabilities have also been useful
to genomic regulation research. However, key gaps in the portfolio of available core services have been
chromatin accessibility and conformation analyses as well as the current generation of DNA-binding protein
analyses and long read sequencing. The Epigenomics Core will be an upgrade of current facilities and employ
personnel with extensive scientific experience in these areas to provide a range of sequencing technologies and
methods. The significant experience of the PI and staff of operating resources and of transitioning a COBRE-
funded core to full self-sustainability will contribute to the success of the Core. The first impact of the Epigenomics
Core will be to provide sequencing and associated services for user generated libraries of any type (e.g., SLAM-
Seq) and continue providing relevant services such as RNA-Seq. The Epigenomics Core will introduce new
services specifically designed for the RPLs’ research and for genomic regulation research. Chromatin
accessibility (ATAC-seq), genomic localization of DNA binding proteins (ChIP-seq, CUT&RUN, CUT&TAG),
chromatin conformation (Pore-C) and long read nanopore sequencing of RNA (Iso-seq). With the customization
often required of these protocols to meet the needs of the specific projects, the Epigenomics Core will work with
investigators to develop workflows and ‘handoffs’ in the processes between the investigator and the Core. The
Epigenomics Core will work closely with the Artificial Intelligence Core to assist researchers in assessing the
output of these new data types and turning them into biological insights. The Epigenomics Core will give genomic
regulation investigators in Oklahoma the capability to examine a wide range of endpoints critical to their studies.
The development and continued growth of genomic regulation research at OMRF will be achieved through the
Epigenomics Core offering advanced research tools and training to foster independence and to enhance the
innovation and creativity of individual research programs. It will also serve to attract and retain talented
investigators in service of our goal of building a vibrant and self-sustaining genomics regulation research
community in Oklahoma.